Novel Incidental Calcium Evaluation (NICE)

1 PROJECT SUMMARY
2 Coronary artery calcium (CAC), typically measured on gated computed tomography (CT) scans, is the
3 strongest predictor of atherosclerotic cardiovascular disease (ASCVD) events across all populations, including
4 groups underrepresented using traditional risk assessment methods. Despite the predictive ability of CAC
5 imaging, less than 1 million gated CT scans are performed annually in the US vs 19 million non-gated chest CTs
6 performed for reasons other than to measure CAC. Further, underrepresented individuals undergo fewer gated
7 CAC scans because these scans are not typically covered by insurance. When scored manually, non-gated CAC
8 scores predict ASCVD events as accurately as gated CAC scores, but grading CAC severity by visual estimation
9 is qualitative and inconsistent, and reporting varies substantially. Consequently, there is vital, lifesaving
10 information that has been collected but not used to guide preventive interventions for individuals unaware of their
11 increased ASCVD risk.
12 Stanford has developed a deep learning (DL) algorithm that quantifies CAC Agatston scores accurately on
13 routine non-gated chest CTs. We have shown that notifying patients and their clinicians about the presence of
14 incidental CAC dramatically increases statin prescriptions. The Novel Incidental Calcium Evaluation (NICE)
15 study will apply the now FDA-cleared algorithm on non-gated chest CTs performed across 3 geographically
16 diverse health systems (Stanford, MedStar Health, and Mayo Clinic). The study will include ~186,000 diverse
17 patients with non-gated chest CT scans without known ASCVD and follow-up within the 3 health systems.
18 Our team has expertise in preventive cardiology, radiology, epidemiology, health equity, DL, and qualitative
19 methods. First, the NICE study will evaluate the prevalence, epidemiology, and prognostic value of DL-CAC in
20 predicting ASCVD events across a real-world, diverse primary prevention cohort who underwent non-gated chest
21 CTs (Aim 1). Second, the algorithm will be extended to estimate CAC on lung cancer screening low radiation
22 dose CT scans (Aim 2). Automating CAC quantification would allow for the equitable and efficient implementation
23 of joint lung cancer and ASCVD screening programs for the 14.5 million eligible individuals in the US. Third, in
24 partnership with the National Minority Health Alliance, we will conduct focus groups with 100 diverse patient and
25 clinician stakeholders to identify facilitators and barriers to increasing preventive therapies following notification
26 of DL-CAC (Aim 3).
27 NICE will provide compelling evidence to support the immediate implementation of opportunistic screening for
28 and notification of CAC by leveraging routine, non-gated chest CTs already performed for other reasons. This
29 study fulfills the promise of data science approaches to equitably improve cardiovascular disease prevention.

Public health relevance
PROJECT NARRATIVE This study will evaluate and refine an artificial intelligence computer program (an “algorithm”) that can quickly read thousands of CT scans to look for calcium deposits in heart arteries to better predict heart attacks, strokes, and death. The study will also hold focus groups to identify the best way for patients and their doctors to use the information from the algorithm to initiate treatment for heart disease prevention. If the algorithm works as expected, it could be used to automatically screen millions of patients from diverse backgrounds who are unaware of their risk for heart disease and guide them toward lifesaving treatment.